2015 Antimicrobial Peptides Gordon Research Conference & Gordon Research Seminar

? DESCRIPTION (provided by the applicant): The 10th Gordon Research Conference (GRC) on Antimicrobial Peptides will convene in Barga, Italy in May 2015. This highly successful series of GRCs has been a vehicle for driving new interdisciplinary thinking on innate immunity since its initiation in 1997. It is held every other year and is recognized as the premier and single mos important meeting in a scientific field that was recognized in 2011 by a shared Nobel Prize in Medicine and Physiology. The meeting alternates sites between the US and Europe to facilitate attendance by the large international community of scientists active in this research field. Antimicrobial peptides (AMPs) are gene-encoded antibiotics found across all domains of life, and accumulating evidence points to a fundamental role for these peptides in innate immunity in a variety of biological settings. The conference will focus on this ever-expanding multidisciplinary field of study. The program is divided into 9 sessions of oral presentations and ongoing poster sessions; all participants will be urged to present one or the other of these formats. The oral presentations will include two keynote addresses by internationally renowned speakers (Professors Richard A. Flavell and Lalita Ramakrishnan). The opening session will include an oral presentation by the recipient of the Young Investigator Award. Short talks will be selected from key posters, with attention to include senior, junior and student level scientists. The themes addressed in the sessions include: Mechanisms of Biological Activities and Function; The Impact of AMPS on Host Microbiome; Diverse AMP Functions in Innate Immunity; AMP Dysfunction, Dysbiosis and Disease; Putting AMPS to Work. Ample time for organized discussion and informal interaction amongst participants has been included. The organizational philosophy is to encourage diverse participation and to positively include junior scientists, minorities, and individuals with physical limitations and be without gender discrimination. An innovative aspect of this meeting is the pre-conference forum for graduate students and post-docs to exchange new data and ideas in a comfortable setting of peers. As with past meetings in this GRC series, the 2015 conference promises to provide a unique forum for deep scientific exchange on fundamental molecules that mediate immune functions and provide an arena for the discussion of harnessing them into valuable novel pharmaceuticals.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed Gordon Research Conference on Antimicrobial Peptides will assemble a group of both US and International scientists for in-depth discussions of these fundamental molecules of innate immunity. An increasing number of studies have highlighted the importance of antimicrobial peptides in health and disease. With an organizational philosophy to encourage diverse participation, and maintain due consideration of gender issues, junior scientists, minorities, and individuals with physical limitations, this interdisciplinary conference will advance new thinking on aspects of human health, disease mechanisms, and potential therapeutic interventions.